FY21 FACILITIES TASK ORDER E (NCI-OSFM-21-0102)

This project is intended to upgrade the existing fire alarm systems in Buildings 321 & 322 at the Frederick National Laboratory Buildings at Ft. Detrick.